Randomized Pilot Evaluation of a Virtual Reality Parent Training Program for Severe Behavior in Children with Autism

Project Summary
Children with autism spectrum disorder (ASD) frequently engage in severe destructive behavior that presents
significant risks to themselves and others, poses substantial barriers to community integration, and results in
high familial and societal financial impact. Despite the efficacy of behavior analytic (BA) interventions for
decreasing destructive behavior, to produce meaningful outcomes in the natural environment, treatment effects
must transfer to natural change agents, such as parents. Parents are often provided with brief in-person
training with therapists modeling and practicing procedures and relapse is common. Although parent training
on BA interventions for destructive behavior leads to parent skill acquisition, parents experience in-person
training barriers, such as time, financial burden, transportation, and childcare, as well as concerns with the
quality of training delivered, such as unrealistic training with therapists and a lack of comfort with therapist
practice. To address these barriers, we propose to refine and test a novel virtual reality (VR) parent training
tool that allows parents to practice intervention implementation in the comfort of their own home at times
convenient for their schedule and quality barriers by closely resembling scenarios parents encounter with their
own child. Specific aims of this project are to 1) To pilot a fully customizable, in-home VR training tool for
caregivers to learn and practice behavioral strategies for managing their child’s challenging behavior, and 2)
To assess the acceptability, feasibility, and preliminary efficacy of a VR training tool using a randomized pilot
trial with caregivers and clinicians. In this proof-of-concept study, we will determine skills acquired, treatment
fidelity, training adherence, generalization of skills, usability, acceptability, and cost effectiveness of the VR-
based training compared to a standard of care control group who receives in-person training with a therapist.
The program will be customized to match the specific child, specific target behaviors, context in which the
behavior occurs, and specific treatment components. Parents will be exposed to a treatment challenge to
prepare for the durability of children’s destructive behavior. The proposed VR tool is individualized, realistic,
flexible, safe, and has the potential to transform caregiver training programs for ASD, improve outcomes for
children with ASD, and increase caregiver confidence, satisfaction, and well-being.

Public health relevance
Project Narrative The development of the proposed virtual reality (VR) parent training tool maximizes the effect of critically needed parent training for parents of children with autism spectrum disorder (ASD) who engage in severe destructive behavior. The VR training tool addresses access barriers to training by allowing parents to practice intervention implementation in the comfort of their own home at times convenient for their schedule and quality barriers by more closely resembling scenarios parents encounter with their own child than contrived practice opportunities. The proposed customizable VR technology has the potential to (a) be highly impactful for parents by teaching sustainable strategies for managing destructive behavior at home, (b) be efficient and informative for clinicians to collect data to support parents, and (c) mitigate the reoccurrence of destructive behavior by allowing parents to practice implementing intervention during treatment challenges.